DIETARY INTAKE AND CARDIOVASCULAR RISK FACTORS IN EARLY LIFE

To examine the relationship between race, method of feeding, nutrient intake, maternal nutrient intake, and familial aggregation lipid profile, Adiposity and blood pressure.